All of Us Research Program Data and Research Center

Project Summary/Abstract - The All of Us Research Program’s overarching goal is to
transform our understanding of the factors that contribute to health and disease, and
ultimately, to leverage this understanding to inform how we prevent and treat disease.
The All of Us Data and Research Center (DRC) supports operationalizing this vision,
serving as a hub for robust data infrastructure and facilitative support of researchers.